Biobehavioral Predictors of Illness Progression in Adolescent Depression

PROJECT SUMMARY / ABSTRACT
Adolescent depression is a major public health concern associated with significant morbidity and mortality. We
know that adolescent depression varies considerably in severity and course, but its underlying mechanisms
remain unknown. This proposal addresses this concern, aiming to identify biobehavioral predictors of illness
trajectory in adolescents to inform treatment influencing its course. Our overall hypothesis is that reward
dysfunction and its underlying neuro-immunological mechanisms contribute to maintenance of depression in
youth. We propose the following model: (1) peripheral inflammation (e.g., cytokines, kynurenines) is associated
with anhedonia; (2) inflammation extends to the CNS, inducing oxidative stress [↓glutathione (GSH, antioxidant)]
and GABA (inhibitory neurotransmitter) deficits; (3) such neuro-chemical changes alter the reward circuitry,
leading to anhedonia, and contribute to depression progression. In support, we documented that of adolescent
depression’s core symptoms, only anhedonia—reflecting deficits in reward processes—and not irritability was
associated with worse outcome, including suicidality and chronicity. We also reported associations between
circulatory cytokines and kynurenines with both anhedonia and reward neurocircuitry. Utilizing proton MR
spectroscopy (1H MRS), we showed that decreased anterior cingulate cortex (ACC) GABA in adolescent
depression was driven by anhedonia. Additionally, using fMRI, we mapped striatal-based connectivity in relation
to anhedonia and documented distinct neural activation patterns of reward anticipation and attainment—both
reward processes that contribute to anhedonia. In pilot studies, we found that ACC GABA and reward-
anticipation brain activation predicted anhedonia severity at 2-year follow-up. Building upon our compelling
findings to date, we propose a prospective study of reward processes and neuroimmunological mechanisms,
with the goal to identify modifiable pathways predictive of depression course in adolescents. We will study 120
adolescents with depressive symptoms. Three in-laboratory comprehensive clinical evaluation and computerized
reward task sessions will be done at baseline, 12-, and 24-month follow-ups. At baseline and 12 months, visits
will include: a) immune blood collection for kynurenine metabolites, immune cell profiling, and cytokine secretion
post immune stimulation (as a biological stressor); b) fMRI resting state and tasks examining distinct reward
processes (e.g., anticipation, attainment, learning); and c) 1H MRS to probe ACC GABA and striatal GSH as
indices for inflammatory neurometabolic consequences in reward-related brain regions. Outcome measures will
include anhedonia severity (primary), along with depression severity, functioning, anxiety, and suicidality.
Principled variable selection approach will address multiple comparison concerns. Dynamic causal modeling and
machine learning classification methods will explore the relationships among all examined factors.

Public health relevance
PROJECT NARRATIVE Our overall goal is to better understand the mechanisms contributing to the maintenance and severity of adolescent depression. A prospective multimodal study will test the overall hypothesis that reward dysfunction and associated neuroimmunological abnormalities contribute to depression progression in youth. Such work would provide information on modifiable factors to facilitate novel treatment approaches influencing the course of illness early on and prior to chronicity effects, so that we may work to ameliorate morbidity and mortality of this devastating disorder.